Investigating the heterogeneity of glucose transport in lung adenocarcinoma

Project Summary/Abstract
Lung cancer is the leading cause of cancer-related death; lung adenocarcinoma (LUAD) is the most
frequent type. The pathogenesis of LUAD is poorly understood. We recently discovered that sodium-glucose
transporter 2 (SGLT2) is a previously unrecognized system of metabolic supply specifically active in early-
stage LUAD and required for lung carcinogenesis. SGLT2 inhibition prolongs survival, delays cancer
development, and slows tumor growth in genetically engineered murine models (GEMMs) and in patient-
derived xenografts (PDXs) of LUAD. Pre-malignant lesions and early-stage LUADs express SGLT2 but not the
well-known GLUT1 transporter, whereas more advanced tumors display heterogeneous expression of SGLT2
in low-grade and GLUT1 in high-grade areas of the same tumor. Why do tumors need to switch from SGLT2 to
GLUT1 as they progress? Our data suggest that this switch is associated with a reprogramming of glucose
metabolism: SGLT2+ tumors use oxidative glucose metabolism, GLUT1+ tumors use glycolysis. Glucose
uptake can be studied in vivo by positron emission tomography (PET) with 2-[18F] fluorodeoxyglucose (FDG),
transported by GLUTs and not SGLTs, and methyl 4-[18F]fluorodeoxyglucose (Me4FDG), specific for SGLTs.
We will investigate the heterogeneity of glucose transport in LUAD, to understand the biological
significance and the mechanisms that regulate the expression of SGLT2 and GLUT1. In Aim 1, we will
characterize glucose metabolism in Me4FDG+ versus FDG+ tumors in GEMMs and in PDXs by PET imaging,
respirometry, metabolomics, metabolic tracing, histology, and transcriptomics, with or without CRISPR
knockout or overexpression of SGLT2 and GLUT1. In Aim 2, we will investigate the role of GSK3 kinase, which
we identified as an SGLT2 regulator, in the regulation of metabolic/differentiation programs associated with the
switch from SGLT2 to GLUT1. In Aim 3, we will investigate the role of hypoxia in the switch from SGLT2 to
GLUT1 expression as LUAD progresses from well- to poorly differentiated, including correlation between FDG
or Me4FDG uptake with markers of hypoxia (F-MISO, pimonidazole), and evaluation of the effect of hypoxia-
inducible factors knockout on SGLT- and GLUT-dependent uptake.
The goal of the proposed research is the elucidation of a novel mechanism of metabolic reprogramming
in cancer: switching between two different glucose transporters, cancer cells can redirect the metabolic fate of
glucose towards different pathways; this observation has important implications as interfering with the Warburg
effect or with glucose transport has been proposed as a novel therapy for cancer; the ability of cancer cells to
change their metabolism by switching glucose transporters is a potentially targetable mechanism of resistance,
as there are specific inhibitors of both SGLT2 and GLUT. Moreover, the availability of PET tracers that can
selectively measure SGLT or GLUT activity in vivo (Me4FDG and FDG, respectively) is a promising tool for
characterizing the metabolic phenotype of cancers in vivo, in order to predict their response to treatments.

Public health relevance
Project Narrative Cancers use two different types of transporters to take up the glucose they need to grow: SGLT2 and GLUT1; we found that early-stage lung cancers use SGLT2, while more advanced lesions switch to GLUT1. We are going to investigate the metabolic function of the switch between SGLT2 and GLUT1, and the mechanisms by which the cells can induce this switch. This is relevant because metabolic inhibition is at the basis of novel targeted therapies for lung cancer, but the switch from one transporter to the other represents a strategy of cancer cells to develop resistance to therapy, which needs to be addressed in order to improve patient survival.